THE RNA HELICASE EIF4A IS A THERAPEUTIC VULNERABILITY IN TRIPLE-NEGATIVE BREAST CANCER

1 This application is being submitted in response to the Notice of Special Interest (NOSI)
2 identified as NOT-CA-22-039. Triple negative breast cancer (TNBC) is a biologically
3 heterogeneous and clinically important breast cancer subtype because if it were considered a
4 distinct disease, TNBC would rank as the 5th leading cause of cancer deaths in women. TNBC
5 also is more prevalent in younger premenopausal women especially Black or African Americans.
6 Protein translational regulation has been demonstrated to be a potential vulnerability in cancer
7 including TNBC. The eIF4A RNA helicase is a key regulator of translation initiation as part of the
8 eIF4F translation initiation complex. Interestingly, eIF4A selectively inhibits the translation of many
9 oncogene and growth factor mRNAs with highly structured 5’UTRs and is an essential gene in
10 many cancer cell lines. eFFECTOR Therapeutics has developed an improved eIF4A inhibitor,
11 Zotatifin (eFT226), that is currently being evaluated in a Phase I clinical trial (NCT04092673) in
12 patients with advanced solid tumor malignancies. In collaboration with eFFECTOR, we have
13 performed studies to determine the efficacy of Zotatifin in syngeneic genetically engineered
14 mouse (GEM) TNBC models developed in our laboratory. In these models a marked improvement
15 in tumor regression and time to end point was observed following combination treatment of
16 Zotatifin with standard-of-care either carboplatin or docetaxel. We now propose to expand these
17 studies to a series of racially and ethnically diverse TNBC PDX models with a special focus on
18 those derived from underserved populations in order to better identify which patients might benefit
19 from combination therapy in future clinical trials. Analysis of eIF4A protein expression across
20 TNBC PDX models has identified models with markedly different levels of Zotatifin target
21 expression. We now propose to optimize and elucidate mechanisms of single agent and
22 combination therapy with Zotatifin and chemotherapy across several high and low eIF4A PDX
23 models and to develop biomarkers to predict response. Our previous studies in GEM models
24 identified changes in the myeloid immune microenvironment including decreased infiltration of
25 neutrophils and repolarization of tumor associated macrophages to a less immunosuppressive
26 and more tumor inhibitory phenotype. Thus, we will also study effects of Zotatifin and
27 chemotherapy on circulating and tumor associated myeloid cells in these PDX models. In
28 summary, these preclinical studies may help provide key information to inform the design of future
29 clinical trials. Although these studies are initially focused on TNBC they may have a broader
30 application to other solid cancers.

Public health relevance
Project Narrative The proposed studies will leverage racially and ethnically diverse PDXs to determine whether Zotatifin (eFT226), developed by eFFECTOR Therapeutics a chemically designed Rocaglate derivative shown to have improved drug-like properties and the first in class eIF4A inhibitor will be effective as both as a single agent and in combination with chemotherapy in triple negative breast cancer. Zotatifin is currently under Phase I clinical trials as a single agent in advanced solid tumors (NCT04092673) and in COVID-19 (NCT04632381). We anticipate identifying mechanisms and biomarkers that correlate with response in underrepresented patient models to guide ongoing and future clinical trials.